Cellular Mechanisms of Lysosomal Damage Response

PROJECT SUMMARY
Lysosomes are essential membrane-bound organelles that play a vital role in cellular degradation and signaling.
Damage to lysosomes can be triggered by numerous physiological and pathological conditions, significantly
threatening cellular function and survival. Consequently, lysosomal damage is associated with an array of human
diseases including cancer, infectious and neurodegenerative diseases, as well as normal aging. Therefore,
studying cellular responses to lysosomal damage holds substantial clinical importance. My postdoctoral research
provided novel evidence about the molecular aspects of these responses. Additionally, a recent first-author
publication, before becoming a Tenure-track Assistant Professor (1/2023), provided the first evidence that
lysosomal damage induces the formation of stress granules (SGs). SGs are stress-induced membrane-less
organelles believed to protect cells during stress by regulating protein synthesis and prioritizing cellular functions.
Although dysfunctional SGs are significantly linked to pathogenic processes of various human diseases, there
is a significant knowledge gap regarding the regulation and precise function of SG formation during stress,
especially in the context of lysosomal damage. Importantly, recognizing lysosomal damage as a critical internal
physiological trigger for SGs highlights the need to better understand the nature of SG formation in disease
contexts. Additionally, this novel connection between damaged lysosomes and SGs emphasizes the interplay
between membrane-bound and membrane-less organelles, a largely unexplored field of research. Recent
preliminary data from my laboratory illustrates that SG formation safeguards lysosomal quality, thereby
promoting cell survival. Notably, we also recently published the first evidence that SG-localized proteins can
associate with damaged lysosomes, serving additional (largely unknown) functions beyond SG formation.
Building on the established platform of seminal work on lysosomal damage, the proposed investigations will
focus on two primary goals: (1) Establishing the precise function of SG formation in controlling lysosomal quality,
and (2) Determining how lysosomal damage induces SG formation. These goals will be achieved by investigating
the function of SGs as organelles and the independent novel activities of SG proteins in controlling lysosomal
quality, and defining the molecular mechanisms that transmit signals from lysosomal damage to initiate SG
formation, respectively. To complete the two primary goals, the multidisciplinary and diverse team will employ
state-of-the-art approaches including high-content microscopy, lysosome immunoprecipitation, proteomic
analysis and RNAi screening. Collectively, the investigations will reveal novel insight into how cells respond to
lysosomal damage, the precise nature of SG formation, and inter-organelle interactions under stress conditions.
These findings have the potential to facilitate innovative therapies directed at addressing diseases associated
with lysosomes and SGs. Success in the proposed application will foster a unique research direction for important
breakthroughs in my early independent research career, aligning with the objectives of the MIRA program.

Public health relevance
PROJECT NARRATIVE Damaged lysosomes and dysfunctional stress granules have become increasingly associated with a wide range of human diseases and have important clinical applications. Pioneering research I conducted before achieving an independent faculty position was the first to demonstrate that lysosomal damage triggers stress granule formation. The proposed research will elevate these findings by providing insight into the relationship between lysosomal damage and stress granule formation, thereby offering the potential to promote significant advancements in therapeutic interventions.